DIETARY IRON AND PROTEIN IN ANEMIA OF PREMATURITY

This protocol is defining the proper role of iron and protein in the management of the preterm infants and exploring the independent contributions of inadequate intakes of iron and protein in the causation of neonatal anemia.